Pathological cardiolipin remodeling links mitochondrial dysfunction to inflammaging

ABSTRACT
Aging is characterized by progressive decline in tissue and organ function leading to increased risk
of age-related diseases. Among diverse factors that contribute to aging, mitochondrial dysfunction and
chronic, sterile, low-grade inflammation have emerged as the major hallmarks of aging process and are
linked to the development of numerous age-related diseases. Emerging evidence suggests that the two
phenomena are interrelated. In particular, circulating cell-free mitochondrial DNA (mtDNA) has been
proposed as a functional link between mitochondrial damage and systemic inflammation, yet the
underlying mechanisms remain largely unknown. Cardiolipin (CL) is a mitochondrial signature
phospholipid that is required for mitochondrial membrane structure, dynamics, biogenesis, and
mitophagy. We and others have previously shown that the onset of aging causes pathological
remodeling of CL by polyunsaturated fatty acids (PUFA). Enrichment of PUFA renders CL highly
sensitive to oxidative damage, leading to CL depletion and mtDNA release. Our previous studies
identified acyl-CoA lysocardiolipin acyltransferase 1 (ALCAT1) as a key enzyme that catalyzes the
pathological remodeling of CL in age-related diseases. Defective CL remodeling by ALCAT1 leads to
oxidative stress and mtDNA instability. Consequently, ablation of ALCAT1 effectively protected mice
from the development of various age-related diseases. Our preliminary studies also identified a striking
role of ALCAT1 in regulating cellular senescence and immune response in aging. ALCAT1 deficiency
significantly attenuates high-fat-diet induced cellular senescence and mitigates lipopolysaccharide
induced inflammation in mice. In contrast, overexpression of ALCAT1 causes cytoplasmic release of
mtDNA and activates the cyclic GMP-AMP synthase-stimulator of interferon genes (cGAS -STING)
pathway. Strikingly, ablation of ALCAT1 extends the lifespan of normal mice and the mitochondrial DNA
polymerase γ (Polg) D257A mutator mice (Polgm/m), a premature aging mouse model. These exciting
findings lead us to hypothesize that pathological CL remodeling by ALCAT1 promotes
inflammaging by activating the cGAS-STING pathway through stimulation of cytosolic mtDNA
release. By using the aging mice models and primary cells, the hypothesis will be tested by two specific
aims: Aim1 will determine whether ALCAT1 causes cellular senescence and inflammaging by
promoting mitochondrial dysfunction through pathological CL remodeling; Aim2 will identify the
underlying molecular mechanisms by which pathological CL remodeling link mitochondrial dysfunction
to inflammaging. The completion of the proposed studies is expected to provide key insights on
pathological CL remodeling by ALCAT1 in mediating mitochondrial dysfunction, cellular senescence
and inflammaging, which will lay a foundation to target ALCAT1 as a novel and potent treatment for
age-related diseases.

Public health relevance
PROJECT NARRATIVE Mitochondrial dysfunction, cellular senescence and chronic inflammation have emerged as the major hallmarks of aging. Emerging evidence suggests that these phenomena are interrelated, but the underlying causes of mitochondrial dysfunction to cellular senescence and chronic inflammation during aging remain largely unknown. The proposed studies will determine the underlying molecular mechanisms by which pathological cardiolipin remodeling by ALCAT1 mediates mitochondrial dysfunction to cellular senescence and inflammaging using the normal aging mice, the premature aging mitochondrial DNA polymerase mutator mice, and the p16-3MR mice models.